Field Instrument for Assessment of Arsenic Exposure

Project Summary
Human exposure to toxic heavy metals existing in drinking water, food, and the environment is an area of
increasing national and international concern. Heavy metals are significant environmental pollutants because
they tend to persist, bioaccumulate and can result in serious adverse acute or chronic health effects after
ingested or inhaled. Traditionally, trace metals are measured from human tissues or fluids (blood or urine) in
centralized laboratories using complex analytical methods such as high-performance liquid chromatography
(HPLC) or inductively coupled plasma mass spectroscopy (ICP-MS). However, in view of the intensive labor,
analytical costs and long turnaround times associated with centralized laboratory analyses, there is an immediate
need for a portable and inexpensive system for on-site monitoring of human exposure to heavy metals. These
rapid, field measurements of human exposure in the population would greatly help epidemiology researchers to
conduct their studies and also help the regulatory institutions with better determination of safety limits and
prevention of diseases caused by heavy metal exposures.
An important goal of this Direct to Phase II proposal is to develop a technology that meet the technical and
practical needs of environmental researchers, clinicians, and epidemiologists. The ultimate goal is to deliver a
reliable field prototype of a sensing instrument for the current unmet needs for rapid testing of trace amounts of
metals in urine samples, and to accelerate the commercialization of this product. In this Phase IIB study, Giner
will develop and demonstrate the heavy metals monitor prototype from bench-top assay platform to a field-ready
instrument with a portable size, with integrated components for assay operation, electronic units and software
packages for data processing and user interface. Meanwhile Giner will develop and fabricate a series of
disposable microfluidic lab-on-a-chip cartridge for convenient measurements of multiple metal(s) and metal
combinations from large numbers of human subjects. The various cartridge designs will allow the monitor
instrument to determine the presence and concentrations of multiple metals. The overall performances of the
prototype will then be evaluated thoroughly through a large scale of field testing with four renowned epidemiology
collaborators, as well as a team of user experience specialists, which would improve the sensing capabilities,
tool reliability and usability towards commercialization.
This proposed project will achieve a critical step towards the commercial release of a heavy metal field monitor,
which has the potential to become a critical tool to support environmental and public health community for
developing strategies to prevent toxic metals-related diseases. Giner is teaming up with leading commercial
partners which specialize in the development and commercialization of screening and diagnostic technologies.

Public health relevance
Project Narrative Giner, Inc. will develop a portable, accurate, rapid-response, versatile, and affordable field instrument for monitoring human environmental exposure to multiple heavy metals. This work will focus on rapid testing of urine samples with high accuracy. A low-cost, on-site instrument will enable near real-time monitoring of heavy metal exposures in at-risk populations and better attending to the technical and practical needs of epidemiologists.